Creation of the Novel Interventions Caution (NIC) Measure to Assess Patient Behavior Towards Unregulated Stem Cell Interventions

Project Summary/Abstract
There are over 1,200 clinics in the U.S. marketing scientifically unsubstantiated stem cell interventions (SCIs)
outside federal regulation and oversight. One major risk to patients from unregulated SCIs is the harm of being
misinformed. This has led tens of thousands of patients to take an unregulated SCI resulting in physical,
financial, and emotional harm. Our aging population with chronic diseases is the main target of stem cell
commercials and are a unique group of health consumers who actively seek information on the internet for
unregulated SCIs, for which misinformation is frequently promulgated. Our exploratory, NIH-supported
research aims to evaluate patient beliefs and behaviors towards unregulated SCIs and the factors that
influence their views on the credibility of information to create pilot health communication interventions. To
date, no research has constructed theory-informed and empirically-robust health communication interventions
that correct misinformation and enhance autonomy by infusing an appropriate sense of caution toward risky
novel health interventions, particularly those given outside of a clinical trial. The overall goal this proposal is to
create and validate a new patient-reported Novel Interventions Caution (NIC) measure to assess the
psychosocial and behavioral determinants (e.g., perceived risks/benefits, expected outcomes, behavioral
intent) of participation toward novel interventions, including SCIs. This crucial measurement step will position
us to test the effectiveness of future health communication interventions aimed at correcting (or inoculating
against) misinformation about unregulated SCIs. Our two specific aims are (1) to develop the conceptual
framework to define the relationship among constructs that influence participation in unregulated SCIs,
generate items for the NIC measure, and assess content validity through a Delphi approach using an expert
panel and patient cognitive interviews; and (2) to assess the psychometric properties of the NIC measure
examining dimensionality, internal consistency reliability, and convergent validity. The measure will be sent to
participants using two national databases, including one we have previously characterized and been able to
successfully recruit patients. Our work will be the first to delineate the psychosocial and behavioral
determinants that influence older, chronic disease patient decisions about unregulated SCIs. This research is
particularly innovative because it applies state-of-the-art survey methodology to a new topic area – novel
interventions including SCIs. Upon completion of this proposal, we will have the required prerequisite data on
outcome measure distributions and necessary pieces for a pilot pre-post evaluation that will culminate in a
larger, prospective randomized trial R01 application. Crafting credible, salient messages that effectively
counter misinformation about unregulated SCIs and elicit caution towards risky interventions will serve to
address the unmet needs of a growing aging, comorbid group of health care consumers.

Public health relevance
Project Narrative Over 1,200 clinics throughout the U.S. provide unregulated stem cell procedures to older adult patients for a host of chronic diseases that have resulted in physical, economic and emotional injuries, including the harm from being misinformed about the effectiveness of stem cell procedures. Our ongoing research aims to evaluate patient beliefs and behaviors towards unregulated stem cell procedures and what influences their views on the credibility of information to create pilot health communication interventions. This study proposal will develop and validate a new patient-reported Novel Interventions Caution (NIC) measure that can be used in future studies to assess the effectiveness of health communication tools at correcting misinformation and eliciting a sense of caution toward novel and risky interventions outside of a clinical trial, including unregulated stem cell procedures.